Uric Acid as a Mediator of Endothelial Dysfunction in Patients with CKD

DESCRIPTION (provided by applicant): The purpose of this proposal is to foster the scientific development and laboratory skills of the candidate, Dr. Jalal, so that she may become an independent investigator, who can perform clinical translation research. The Renal Division in collaboration with the Clinical and Translation Research Center at the University of Colorado Denver are in a position to provide Dr. Jalal with the optimal environment to examine the impact of lowering serum uric acid levels on endothelial function, at the clinical, biochemical, and cellular level, in patients with moderate chronic kidney disease (CKD). Dr. Jalal is currently as assistant professor at the University of Colorado at Denver Health Sciences Center. Through her primary mentor, Dr. Johnson, and an extensive network of experienced scientific and clinical researchers, Dr. Jalal will obtain the foundation for the development of an independent academic career. Endothelial dysfunction, inflammation, and oxidative stress are prevalent in patients with CKD, and play a central role in atherosclerosis and in CKD progression. Due to a variety of factors, patients with CKD are hyperuricemic. Uric acid has been implicated in the etiology of endothelial dysfunction. Experimental evidence suggests it mediates its downstream effects on the vasculature via inflammation and oxidative stress. We hypothesize that uric acid induces oxidative stress and inflammation, and contributes to endothelial dysfunction in patients with stage III CKD who are also hyperuricemic. In her grant, Dr. Jalal proposes a randomized controlled clinical trial, where 80 patients with stage III CKD and serum uric acid levels acid > 7mg/dL will be randomized to either placebo or allopurinol for 3 months. The specific aims of the proposal include: 1. determine of lowering serum uric acid improves endothelial dependant dilation by measuring brachial artery flow mediated dilation, 2. determine that lowering serum uric acid levels will mitigate systemic inflammation and oxidative stress, and 3. determine that lowering serum uric acid levels will curb endothelial cellular activation of inflammatory and oxidative pathways by immunofluorescence. For each of these specific aims, measurements will be obtained at baseline and the end of the study period, and changes from baseline will be contrasted between the group randomized to allopurinol and the group randomized to placebo. The results of this study will answer an important clinical question, and will result in publishable work. In addition, the findings of this trial will likely set the stage for larger clinical trials to evaluate the impact of uric acid lowering therapies on cardiovascular events and CKD progression in patients with mild- moderate CKD.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are proposing a clinical trial to test that hypothesis that lowering serum uric acid levels with a xanthine oxidase inhibitor (allopurinol) will improve endothelial function, inflammation, and oxidative stress at the clinical, biochemical, and cellular level, in patients with stage III CKD who are also hyperuricemic. This application presents an ideal vehicle for training in clinical research, as the Renal Division at the University of Colorado Denver is in a strong position to enable the candidate to complete the proposed study. This award will allow for formal course work to obtain a doctorate degree in clinical research, publications and participation in national conferences, and the establishment of collaborative relationships. In addition, it will educate the candidate in endothelial cell recovery and protein expression, a technique that can be utilized in other studies in the future. The proposed study will result in publishable findings, and may lead to larger clinical trials aimed to evaluate the impact of uric acid lowering agents on outcomes in patients with CKD. Project Narrative We are proposing a clinical trial to test that hypothesis that lowering serum uric acid levels with a xanthine oxidase inhibitor (allopurinol) will improve endothelial function, inflammation, and oxidative stress at the clinical, biochemical, and cellular level, in patients with stage III CKD who are also hyperuricemic. This application presents an ideal vehicle for training in clinical research, as the Renal Division at the University of Colorado Denver is in a strong position to enable the candidate to complete the proposed study. This award will allow for formal course work to obtain a doctorate degree in clinical research, publications and participation in national conferences, and the establishment of collaborative relationships. In addition, it will educate the candidate in endothelial cell recovery and protein expression, a technique that can be utilized in other studies in the future. The proposed study will result in publishable findings, and may lead to larger clinical trials aimed to evaluate the impact of uric acid lowering agents on outcomes in patients with CKD. __SpecificAimsTextDelimiter__ B) HYPOTHESIS AND SPECIFIC AIMS Cardiovascular disease is the number one cause of death in patients with chronic kidney disease (CKD) 1. Endothelial dysfunction, inflammation, and oxidative stress represent a pro- atherogenic phenotype that is highly prevalent and contributes to the high incidence of cardiovascular disease in patients with CKD 2. Uric acid is elevated in patients with CKD 3, and experimental evidence links uric acid to endothelial dysfunction, inflammation, and oxidative stress 4. Yet, the role of uric acid as a mediator of endothelial dysfunction, in patients with CKD, is unexplored. Through this proposal we will identify uric acid as a mediator of endothelial dysfunction and systemic and cellular inflammation and oxidative stress in patients with moderate CKD. Allopurinol, a xanthine oxidase inhibitor, is safe and effective in lowering serum uric acid levels in patients with CKD with the proper dose adjustment 5. Thus allopurinol will be used to lower serum uric acid levels in the enrolled patients. Published results demonstrate that serum uric acid levels are an independent risk factor for cardiovascular events in various high risk populations 6-9, including patients with moderate and advanced CKD 10. In patients with CKD, serum uric acid levels have been shown to correlate with markers of systemic inflammation such as high sensitivity C-reactive protein (hs-CRP) 11. Our preliminary data demonstrate that, serum uric acid levels are a strong predictor of incident albuminuria (a marker of endothelial dysfunction) in patients with type I diabetes and that uric acid directly induces oxidative stress via the activation of nicotinamide adenine dinucleotide phosphate-oxidase (NAD(P)H oxidase) enzyme in human endothelial cells in vitro. In addition, we show that hs-CRP and CKD synergistically predict an increased risk of cardiovascular disease in individuals > 55 years of age. Hence, our overall hypothesis is that uric acid induces oxidative stress and inflammatory Figure.2. Uric Acid and CKD: a vicious cycle? Reduced GFR + renal vascular resistance Uric Acid Insulin resistance Diuretics Dietary factors Inflammation Endothelial NF- B Oxidative stress dysfunction CRP NAD(P)H oxidase NO MCP-1 Atherosclerosis activation in the endothelium of patients with moderate CKD, and contributes to the endothelial dysfunction commonly seen in this patient population. To examine this hypothesis, we propose a prospective, double-blinded clinical trial, randomizing patients with CKD stage III and serum uric acid levels > 7.0 mg/dL to allopurinol versus placebo for 3 months and examining the following specific aims: Specific Aim 1. Determine that lowering serum uric acid levels, by allopurinol, improves conduit artery endothelium-dependant dilation (EDD). Hypothesis to be tested: uric acid is a mediator of endothelial dysfunction in patients with CKD. Specifically, we will measure brachial artery flow mediated dilation (BA- FMD), and contrast the change from baseline between the group randomized to allopurinol versus the group randomized to placebo. Specific Aim 2. Determine that lowering serum uric acid levels mitigates systemic inflammation and oxidative stress in patients with CKD III. Hypothesis to be tested: uric acid induces systemic inflammation and oxidative stress in patients with CKD. Specifically, we will measure plasma levels of the following: hs- CRP, interleukin 6 (IL-6), and monocyte chemotactic protein-1 (MCP-1), as markers of inflammation, and oxidized low density lipoprotein cholesterol (oxLDL), asymmetric dimethylarginine (ADMA), and 8- isoprostanes, as markers of oxidative stress. Specific Aim 3. Establish that lowering serum uric acid levels curbs inflammatory activation and oxidative stress in venous endothelial cells of patients with stage III CKD. Hypothesis to be tested: uric acid activates inflammatory pathways and leads to oxidative stress and injury in the endothelial cells of patients with CKD. Specifically, we will perform immunohistochemistry on venous endothelial cells recovered from the participating individuals for the expression of the following proteins: intercellular adhesion moecule (ICAM-1) and nuclear factor κ-B (NFκ-B p65) as inflammatory mediators, and nitrotyrosine and Nox4-containing NAD(P)H oxidase complexes as indicators of oxidative stress. In addition, since decreased NO availability may be the result of decreased endothelial nitric oxide synthase (eNOS) expression, we will stain for eNOS. Together the above studies will specifically reveal that lowering serum uric acid levels by xanthine oxidase inhibition modulates endothelial dysfunction, inflammation, and oxidative stress. More generally, the proposed work will set the stage for large clinical trials examining the impact of uric acid lowering therapies on cardiovascular events and mortality in patients with mild- moderate CKD, as well as on the progression of the underlying CKD.